Leveraging Ethnic Anotia-microtia Disparities for Discovery (LEADD) Study

PROJECT SUMMARY
Anotia/microtia is a birth defect characterized by an absent or hypoplastic external ear; it is estimated that
>80,000 Americans are living with this condition, which causes significant hearing loss in >75% of affected
individuals. This study will identify social/environmental and genetic drivers of anotia/microtia, with an
emphasis on addressing health disparities for Hispanic/Latinx populations. Notably, the birth prevalence of
anotia/microtia is increased in Hispanic relative to non-Hispanic white populations, but Hispanic infants are less
likely to be diagnosed with an anotia/microtia syndrome than their non-Hispanic white peers. This study will
use a three-part approach. First, by leveraging data on >10 million live births and >3,500 cases with
anotia/microtia from population-based birth defects registries in California and Texas, it will evaluate the extent
to which sociodemographic factors explain differences in the birth prevalence of anotia/microtia syndromes
between Hispanic and non-Hispanic populations. Second, using an ancestry-aware genome-wide association
method (Tractor), archived biospecimens from the California Biobank Program and National Birth Defects
Prevention Study, and publicly available whole-genome sequencing data from the Gabriella Miller Kids First
Pediatric Research Initiative, it will identify genetic variants associated with anotia/microtia in Hispanic and
non-Hispanic individuals. Next, it will apply a rigorous machine learning technique to data from the National
Birth Defects Prevention Study (N=699 cases with anotia/microtia and >10,000 controls without birth defects)
to identify maternal exposures associated with anotia/microtia in Hispanic and non-Hispanic populations.
Finally, it will perform an integrative assessment of the role of sociodemographic, genetic, and maternal factors
in determining risk for anotia/microtia. In accomplishing these objectives, the study will: identify drivers of
disparities in anotia/microtia among Hispanic populations; shed light on the etiology of anotia/microtia in
diverse populations by characterizing genetic variants associated with this disease, which will be targets for
future investigation; and identify potentially modifiable maternal exposures that could be used to facilitate
prevention.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to identify risk factors for anotia and microtia in Hispanic and non-Hispanic populations. This proposal will accomplish its objective by evaluating the associations of individual and neighborhood-level social/environmental factors, genetic variation, and maternal exposures with anotia and microtia, using data from population-based birth defects registries, biobanking programs, and the National Birth Defects Prevention Study. This information may inform future etiologic studies, facilitate targeted prevention efforts in high-risk populations, and reduce ethnic disparities in the prevalence, diagnosis, and treatment of anotia and microtia.